A Forward Genetic Screen to Identify Genes Involved in Amphetamine Action

Project Summary
Amphetamine (Amph) and Amph-like drugs are commonly abused psychostimulants that come
with a high addiction liability. Numerous studies have shown that Amph alters the function of
various proteins in the brain. Among others, proteins linked to dopamine signaling are major
targets of Amph. However, despite decades of active research, the full picture of how Amph
generates addiction remains far from completely understood. For example, while it is well
accepted that the increase of extracellular dopamine induced by Amph, as well as by all other
addictive drugs, is the first step toward addiction, it is unknown how this increase in dopamine
generates physiological and behavioral modifications that ultimately lead to addiction. To identify
novel proteins that will help us to elucidate the mechanism of action of Amph, we have designed
a forward genetic screen using mutated strains from the Million Mutations Project (MMP). The
MMP is a collection of C. elegans mutants containing already mapped and identified mutations
in specific genes. Thus, using the MMP strains for a genetic screen facilitates the identification
of the gene required for the behavior the screen was set for. We will screen these mutants for
Amph-induced behaviors and select animals that do not respond to Amph treatments or exhibit
a hyper-response to Amph. Then, using the MMP database and the genetic tools offered by C.
elegans, we will identify the genes responsible for the altered response to Amph.

Public health relevance
Narrative Despite many years of investigation, the exact mechanism of action of amphetamine (Amph) and Amph-related drugs remains mostly unknown. Using the powerful genetic system C. elegans, we designed a forward genetic screen to identify novel proteins recruited by Amph. Data collected from this application will also elucidate whether or not dopamine is an essential factor without which Amph cannot induce behavioral effects.